Identification of isoform-specific WT1 interaction partners

PROJECT SUMMARY
Wilms’ tumor 1, or WT1, is a transcription factor that plays an essential role in both nephrogenesis and
maintenance of the adult podocyte. Variants in WT1 can cause Wilms tumors, progressive
glomerulopathy, and disorders of sex differentiation in humans. WT1 also plays a role as either a tumor
suppressor or oncogene in a context-dependent manner in both hematological malignancies and solid
tumors. There are at least 36 different WT1 isoforms generated by alternate start sites and splicing.
Two common isoforms, designated WT1-KTS and +KTS, differ in the presence or absence of three
amino acids, lysine-threonine-serine, between the protein’s third and fourth zinc fingers and result from
alternate splice sites in intron 9. Interestingly these two isoforms exhibit different nuclear localization
patterns and DNA-binding affinity, and have been shown to have distinct yet overlapping cellular roles.
Although the role of WT1 in the developing and mature kidney has been the subject of many research
endeavors, there remain several critical gaps in our understanding of WT1 biology: 1) the factors that
regulate WT1 transcriptional activity are unknown; 2) the function of the WT1+KTS isoform has not
been fully characterized; and 3) the mechanisms by which human WT1 mutations disrupt WT1+KTS
function have not been studied. We aim to apply novel proteomic approaches including proximity
labeling and quantitative mass spectrometry to address these knowledge gaps. In Specific Aim 1, we
propose to apply proteomic techniques to identify overlapping and unique interaction partners of the
WT1-KTS and WT1+KTS isoforms. In Specific Aim 2, we will apply similar techniques in addition to
other relevant cell biological assays to determine how WT1 patient variants disrupt protein-protein
interactions and cause disease. Completion of these aims would provide the first successful proteomic
approach to identify WT1 interaction partners, thereby providing a better understanding of the factors
that modulate WT1 transcriptional activity, insight into the differential functions of the WT1-KTS and
WT1+KTS isoforms, and, ultimately, to the development of novel therapeutic strategies for patients with
WT1-related kidney disease.

Public health relevance
NARRATIVE Wilms’ tumor 1, or WT1, is an important regulator of kidney development and is critical for maintenance of the adult podocyte. Human mutations in WT1 lead to a spectrum of clinical phenotypes including heavy proteinuria, progressive kidney dysfunction, risk of Wilms tumor and gonadoblastoma, and disorders of sexual differentiation. Although the downstream transcriptional targets of WT1 have been the subject of prior studies, our understanding of the factors that modulate WT1 function is poor. In addition, there are at least 36 WT1 isoforms arising from alternative splice sites, and the distinct cellular roles of these isoforms are not well understood. The aim of this proposal is to apply proteomic and cell biology techniques to identify WT1-interaction proteins, study how these interactions are disrupted with WT1 patient variants, and to elucidate the differential functions of two main WT1 isoforms. These studies will provide a better understanding of WT1 biology and could lead to the development of novel therapeutic strategies for patients with WT1-related kidney disease.